Mobilizing Innovative Strategies to Improve TB Diagnosis and Retention in the TB Care Cascade for Migrant Communities in New York City

PROJECT SUMMARY/ABSTRACT
Since 2021, TB incidence in New York City (NYC) has surged partly due to decreased
attenƟon during the COVID-19 pandemic and in part due to increased migraƟon across the
southern US border. Approximately 205,000 migrants from TB-endemic regions arrived in NYC
since April 2022. In 2023, TB incidence in NYC rose by 28%, the highest rates in over a decade,
with 89% of cases among individuals born outside the US. Our proposal aims to evaluate
innovaƟve methods to improve TB detecƟon, prevenƟon, and treatment among migrants in
NYC.
IniƟal work by our team in NYC migrant shelters has demonstrated high numbers of
persons with of latent TB infecƟon (LTBI) and acƟve TB. Current clinic-based approaches to TB
surveillance are ineffecƟve since few high-risk persons complete TB screening and fewer are
retained in the TB cascade of care.
The proposed intervenƟon, SPOT-TB (Screening with Portable X-rays for rapid
recOgniTion of TB), evaluates the use of mobile diagnosƟc teams integraƟng ultraportable
digital chest radiography paired with arƟficial intelligence-assisted interpretaƟon, upfront
tesƟng for TB (interferon gamma release assay) and HIV, and community engagement to
improve iniƟaƟon and retenƟon in the TB cascade of care compared to convenƟonal, clinic-
based approaches to TB surveillance.
Aim 1 is to idenƟfy acƟve and latent TB in migrant communiƟes using this mobile
detecƟon platiorm, hypothesizing that it will increase the proporƟon of migrants compleƟng
diagnosƟc evaluaƟon compared to convenƟonal approaches. Aim 2 is to determine the
feasibility and acceptability of the SPOT-TB strategy using mixed methods, hypothesizing that it
will be highly feasible and acceptable to both care workers and parƟcipants. Aim 3 is to evaluate
structural and behavioral barriers to TB care in NYC migrant communiƟes, hypothesizing that
unstable housing will be a fundamental barrier and that perceived TB sƟgma will predict
subsequent loss to retenƟon in the care cascade. This project employs mixed methods to
evaluate the intervenƟon’s feasibility, acceptability, and effecƟveness, uƟlizing advanced
staƟsƟcal techniques to understand complex relaƟonships. The scalable SPOT-TB model aims to
provide a robust framework for improving TB care in urban settings, with data supporƟng future
NIH R01 submissions for larger trials. By enhancing TB detecƟon and care retenƟon, the project
seeks to reduce TB transmission and improve health outcomes for NYC's migrant populaƟon.

Public health relevance
PROJECT NARRATIVE This proposal aims to address the escalating tuberculosis (TB) crisis among recent migrants in New York City by enhancing TB detection, prevention, and treatment. We propose to evaluate a multifaceted approach, SPOT-TB, which integrates ultraportable digital chest radiography paired with artificial intelligence-assisted interpretation, TB and HIV screening, and characterizing behavioral and structural barriers to improve initiation and retention in the TB cascade of care compared to existing conventional TB screening approaches. This project will contribute critical new knowledge to inform prioritization and implementation of future scalable model for TB diagnosis and community engagement for urban settings in the US and globally.